SIV reservoirs dynamics during aging

Abstract
The advancement of combinational antiretroviral therapy (cART) converts the life of people living with HIV
(PLWH) to manageable diseases. However, due to the persistence of viral reservoirs, a cure for HIV remains
elusive. That implies we need to eliminate and/or reduce the size of the viral reservoirs to achieve a cure. It has
been reported that Neonates/infants whose immune system is dominated by naïve T cells with a limited number
of antigen-specific memory T cells have a small HIV reservoir compared to adults. Chronological aging leads to
the clonal expansion of effector memory T cells with simultaneous loss of naïve T cells, resulting in a Naïve-
memory imbalance. In CNS, with aging, the blood-brain barrier (BBB) leakiness keeps increasing, and chronic
activation of microglia/perivascular macrophages occurs. Additionally, aging-associated epigenetic changes in
immune cells result in chronic inflammation in older people. How all these factors impact HIV reservoirs in older
PLWH remains understudied and has significant implications for developing HIV cure research strategies for
aged PLWH. Therefore, this proposal aims to understand how age-associated alterations in composition,
epigenetic state, and functionality of immune cells alter the HIV reservoirs using SIV-infected, ART-treated young
vs. aged rhesus macaques. We will study the age-associated changes in (1) DNA methylation pattern, (2) SIV
integration site, and (3) in composition/functionality of T-cell and monocyte/ macrophages/microglia subsets from
PBMC, lymph nodes, rectal tissue, and brain in young vs. aged macaques. Subsequently, we will measure the
SIV reservoirs in all these cell types. We anticipate that understanding the aging-associated changes in immune
cells at viral reservoir sanctuaries will help to provide a more informed approach to designing HIV cure research
interventions for older people living with HIV.

Public health relevance
Narrative With the introduction of combinational antiretroviral therapy (cART), the average age of people living with HIV (PLWH) increased considerably, and at present in the United States, more than half of the PLWH are aged 50 years or older. The interplay between HIV and aging involves complex immunological changes expected to influence the viral reservoirs. Therefore, this proposal is designed to understand the impact of aging-associated changes in DNA methylation profile and immune cell functions in HIV reservoirs using an SIV-infected cART- treated non-human primate model.